Monitoring the Future: A Cohort-Sequential Panel Study of Drug Use, Ages 19-65

ABSTRACT
This application is for a 5-year continuation of the national longitudinal panel data collections of the Monitoring
the Future (MTF) study, an ongoing epidemiological and etiological substance use research and reporting project
begun in 1975 (N~120,000, 1976-2027). In addition to being a basic research study, MTF has become one of the
nation's most relied upon sources of information on trends in illicit drug, alcohol, and nicotine/tobacco use
among adolescents and young, middle, and older adults in the United States. This MTF Panel application seeks
to continue the longitudinal (web-based) surveys of nationally representative samples of high school students
(modal age 18) at modal ages 19–30, 35, 40, 45, 50, 55, 60, and now 65. The companion MTF Main application
covers in-school data collections of nationally representative samples of 8th, 10th, and 12th grade students and
funding for cross-sectional and longitudinal data analysis. The Main and Panel components together comprise
the integrated MTF study. MTF's broad measurement covers (a) initiation, use, and cessation for over 50
categories and subcategories of licit and illicit drugs, including symptoms of substance use disorders; (b)
attitudes and beliefs about substances, perceived availability, and peer norms; (c) individual risk and protective
factors (e.g., depressive affect, pro-social activities); (d) aspects of key social contexts (e.g., home, work), and
social role statuses and transitions; (e) health, social, and achievement consequences; and (f) risk and protective
behaviors related to the spread of HIV/AIDS. The cohort-sequential longitudinal design permits the
measurement of factors that may explain historical trends and cohort differences. MTF Panel is designed to
document the developmental course of drug use and related attitudes from adolescence through adulthood (ages
18-65), and to determine the predictors and consequences of drug use across the life course. Research on risk
and protective behaviors for the transmission of HIV/AIDS will be a focus, extending the age of monitoring to
those aged 19 to 30. Substance use by college status will continue to be tracked, totaling 45 years of annual trend
data comparing college students and non-college young adults in the U.S. The long-term follow-up will now
include data at age 65 among cohorts who were in high school during historic peaks in teen substance use and
are now facing declining health decades later. Results will continue to elucidate drug use from adolescence
through adulthood—including the use of new drugs and modalities—with important implications for national
policy, research, prevention, and treatment agendas. As our nation sees increases in adolescent and adult vaping
and marijuana use, the need to understand trends in use from adolescence to adulthood and consequences on
health, well-being, and work and family life has never been greater.

Public health relevance
PROJECT NARRATIVE This proposal is to continue the ongoing Monitoring the Future (MTF) Panel study, which has surveyed new nationally representative samples of high school seniors every year since 1976 to track patterns and consequences of substance use and HIV/AIDS risk and protective behaviors. This application covers five new longitudinal data collections in 2023 through 2027 from national samples of adults ages 19 through 65 (approximately 120,000 people total). This application – the MTF Panel – is part of the integrated MTF study; a companion R01 application (the MTF Main) requests funding to continue (a) to collect annual nationally representative cross-sectional data from secondary school students, and (b) to analyze all cross-sectional and longitudinal data.